Regulation of Coronary Blood Flow

PROJECT SUMMARY
The goal of this project is to gain a better understanding of mechanisms that underlie metabolic coupling
between myocardial oxygen demand and oxygen supply via changes in coronary blood flow to the heart.
Redox-sensitive voltage-gated potassium channels (i.e., Kv1.x) in coronary vascular smooth muscle (CVSM)
are known to be essential to the enhancement of myocardial blood flow (MBF) in response to increased
cardiac workload. How Kv1 channel activity is enhanced in CVSM in response to metabolic signals from an
active myocardium is unknown. Here, we propose an essential role for metabolic regulation of Kv1 channel
activity by the tetrameric assembly of cytosolic auxiliary Kvβ subunits, which are members of the aldo-keto
reductase (AKR) superfamily and bind oxidized and reduced pyridine nucleotides (e.g., NAD(H)) with high
affinity. Our preliminary data are consistent with the global hypothesis that interactions between NAD(H) and
Kvβ1 and Kvβ2 impart precise control over the coupling between regional MBF with cardiac oxygen demand.
In Aim 1, we will delineate the role of coronary Kvβ subunits in the regulation of the metabolic hyperemia
response. To do this, we will use non-invasive myocardial contrast echocardiography (MCE) to measure MBF
as a function of cardiac workload in anesthetized WT and Kvβ-null animals upon administration of
norepinephrine (NE). The cell-specific contribution of Kvβ1 and Kvβ2 in CVSM to metabolic hyperemia will be
examined in double transgenic animals with inducible smooth muscle-specific expression of Kvβ in null
background animals. In vitro electrophysiology and myography will test the relative roles for Kvβ in altering the
voltage-dependence of Kv1 activation and inactivation and metabolic vasodilation, respectively. In Aim 2, we
will elucidate the mechanism of Kvβ-mediated metabolic coupling. We will measure, using electrophysiology,
the relative functional contribution of Kvβ subunits to regulation of Kv1 activity upon specific manipulations in
cellular metabolism that alter the redox ratio of NADH:NAD+ in CVSM. We will quantify changes in
NADH/NAD+ redox in CVSM using genetically-encoded fluorescent biosensors and MALDI-MS imaging, and
determine the role of NAD(H) turnover by Kvβ catalysis in regulation of coronary vasodilation and
enhancement of MBF. In Aim 3, we will clarify the role of Kvβ in cardiovascular adaptation to exercise
conditioning. To do this, we will subject WT and genetically-modified animals to a forced treadmill running
exercise protocol before measuring adaptations in MBF, coronary vasodilatory capacity, and Kv activation and
inactivation properties. This aim will also address the overall dependence of physiological myocardial
adaptations and enhancement of exercise capacity on coronary Kvβ-dependent changes in MBF.

Public health relevance
PROJECT NARRATIVE Recent evidence indicates that defective coupling between cardiac metabolic demand and coronary vascular function contributes to myocardial ischemia in patients with heart disease. We will establish a novel paradigm of myocardial blood flow regulation by elucidating the molecular components that establish the connection between cellular metabolism and vascular smooth muscle excitability. Thus, insights generated during this project could reveal new targets for the development of more effective therapeutic strategies to prevent or reverse ischemia-related cardiac disorders.